Osteoprogenitor mobilization for bone development and repair

Abstract
Large bone defects caused by traumatic injury or tumor resection pose a significant clinical challenge as they
cannot not heal without intervention, and current bone grafting therapies are limited. Tissue engineering is a
promising alternative, but is often limited by poor recruitment or supply of endogenous progenitor cells. Unlike
large defects, bone fractures heal readily by recapitulating the steps of bone development. In fracture repair,
mechanical cues, in the form of interfragmentary strains, are essential to determine the pathway by which bone
formation occurs, namely direct bone formation through intramembranous ossification or indirect bone
formation through endochondral ossification, in which a cartilage template forms first and is later replaced by
bone. The mechanisms by which osteoprogenitor cells are mobilized during bone development and how
mechanical cues direct fracture repair are poorly understood. We observed combinatorial roles of the
mechanosensitive transcriptional co-activators, Yes-associated protein (YAP) and Transcriptional co-activator
with PDZ-motif (TAZ) in promoting both bone development and repair. The goal of this application is to define
the mechanistic roles of YAP/TAZ in osteoprogenitor cell mobilization during bone development and
mechanical load-mediated fracture repair. Accomplishing this goal will provide new insights into developmental
bone diseases, identify pathways that could be exploited to enhance healing, and position us to design new
tissue engineering strategies that recapitulate the processes of bone development and natural repair for
regeneration of large bone defects.

Public health relevance
Project Narrative This project aims to identify the mechanisms by which osteoprogenitor cells are mobilized for natural bone development and mechanical regulation of intramembranous vs. endochondral bone fracture repair.